Developmental Funds

PROJECT SUMMARY/ABSTRACT
Developmental Funds are a key financial resource that Perlmutter Cancer Center (PCC) has used to facilitate
its strategic goals and vision. During the current cycle, these funds were used for two purposes. Support was
provided to two Developing Cores, both of which were highly successful. The Metabolomics Developing Core
is presented as a full shared resource in the current application. Data Core is now an institutionally funded
resource (Data Hub). was to support promising pilot studies in basic, translational, clinical, and population
sciences that aligned with the objectives of the PCC Strategic Plan and address major cancer burdens and/or
disparities in our catchment area. Selected projects were expected to have a high likelihood of producing
important discoveries and publications, future peer-reviewed grants, and/or new intellectual property (IP).
Preference was given to multi-investigator projects with the potential to catalyze new team science that
addresses catchment area needs. Funds were also allocated to novel investigator-initiated clinical trials without
other/adequate sources of funding. Young investigators without significant funding, or more established faculty
who wished to expand their focus to include cancer-related research but who lack external funding for this
purpose, were also considered for Developmental Funds support. Pilot projects are selected by the
Developmental Funds Committee following a rigorous 2-stage, NIH-like review process and managed by the
Administrative Office (AO). The impact of allocated funds as measured by publications, new grant
applications/grants, submitted or issued patents, and/or other intellectual property was monitored by
Developmental Funds Committee, the AO, and the Executive Management Committee to assess the
success of the program. Pilot funds were allocated to all four Research Programs during the current funding
period and were highly impactful. Return on investment was ~570%, as measured by new grant funding. These
funds also yielded multiple impactful papers, new IP, the creation of two biotechnology companies, and several
investigator-initiated trials. Over half of the projects addressed major cancer burdens and/or disparities in the
PCC catchment area. In the next funding period, we propose to support similarly impactful pilot studies. The
Specific Aims of Developmental Funds are: 1) To fund innovative cancer research pilot projects that advance
the overall goals of the Strategic Plan and address the needs of the PCC catchment area, 2) To foster and
develop collaborative, transdisciplinary research involving teams of basic, translational, clinical, and population
investigators, 3) To develop and support young investigators or established faculty with an emerging interest in
cancer-related investigation, and 4) to develop and support novel investigator-initiated early phase clinical trials
and/or interventional studies that support disease management group-related goals and strategies.